OPTIMIZATION OF NANOPARTICLE TUMOR-LOCALIZATION AND DRUG-LOADINGFOR TREATING MESOTHELIOMA

ABSTRACT
A common point of treatment failure in intraperitoneal mesothelioma is cancer recurrence following debulking
surgery. To address this unmet clinical need, a unique nanoparticle-based solution is proposed which employs:
1) A functional pH-responsive “expansile” nanoparticle (eNP) delivery platform, which leverages fundamental
pathophysiological properties of tumors (e.g., mildly acidic extracellular environment and high metabolic rate) to
induce compositional and architectural changes (e.g., particle swelling) that result in tumor-specific accumulation
with enhanced particle penetration and retention both in the extracellular and intracellular tumoral environment.
This “Materials-Based Targeting” approach overcomes limitations of traditional strategies (e.g., enhanced
permeability and retention (EPR) effect, and antibody-based targeting). In addition, the reduced nanoparticle
complexity, compared to antibody labeled nanoparticles, will facilitate large-scale, GMP production of material
necessary for the initiation of future clinical trials.
2) Use of a biodegradable drug-conjugate polymer of paclitaxel (PGC-PTX) that, when co-formulated with the
eNP polymer will afford an ultra-high drug-loaded nanoparticle. These nanoparticles provide exceptionally high
drug loading (40-70 wt%) which will enable delivery of an unprecedented local dose of drug. Furthermore, the
covalent conjugation of paclitaxel ensures prolonged (>60+ days) delivery of paclitaxel with negligible burst
release (<10% in the first 10 days) while avoiding systemic toxicities.
*We hypothesize that the properties of a nanoparticle delivery platform (i.e., PGC-PTX-eNPs) with Materials-
Based Targeting can be optimized to deliver an ultra-high local dose of paclitaxel to peritoneal tumors and
thereby prevent tumor recurrence following surgical resection in mesothelioma cancer models. Importantly, key
preliminary data support the proposed studies, well-characterized materials and rigorous experimental designs
are established, and essential cross-disciplinary collaborations and expertise (nanotechnology, polymer
chemistry, cell metabolism, autophagy, and surgical oncology) are in place to address this hypothesis. The
specific aims of this five year proposal are to: 1) Perform mechanistic studies to determine how chemical
properties, nano-architecture and drug incorporation of PGC-PTX-eNPs impact the Materials-Based Targeting
functionality (e.g., tumor-specificity and intracellular trafficking); 2) Optimize the nanoparticle formulation of PGC-
PTX-eNPs to achieve the maximum antitumor effect against three normal and drug-resistant mesothelioma cell
lines and six patient samples; and, 3) Evaluate the optimized PGC-PTX-eNP formulation to determine the
biodistribution, toxicity, PK, and PD/efficacy in a PDX model of recurrent mesothelioma.

Public health relevance
Narrative Cancer recurrence following surgical resection is one of the foremost challenges in oncology, particularly, in intractable peritoneal cancers such as mesothelioma. This project proposes a nanoparticle-based solution that will deliver a potent high dose of drug specifically to the residual tumor while sparing the patient from systemic side effects—this is achieved with an ultra-high drug-loaded nanoparticle that employs a novel Materials-Based Targeting approach. Successful completion of this work will improve the duration and quality of life for patients with mesothelioma, and may potentially be expanded to the broader cohort of patients with intraperitoneal cancers (e.g., ovarian, pancreatic, etc.).